Hepatitis B virus integrations in KMT2B drive hepatocellular carcinoma

ABSTRACT
Chronic infection by hepatitis B virus (HBV) is the leading cause of hepatocellular carcinoma (HCC). HBV alone
is responsible for more than 3% of worldwide cancer deaths of all cancer sites combined. How HBV promotes
carcinogenesis is not fully understood, leading to limited therapeutic options for advanced diseases. We
previously revealed that 10% of HBV-associated HCC tumors carry clonal integrations of HBV in the KMT2B
gene locus in cancer cell genomes. All these integrations are located between exons 3 and 6 of the KMT2B
gene. KMT2B is the only close homolog of KMT2A (also known as MLL1). It has been well established that the
chromosomal translocations affecting KMT2A are the primary drivers of infant mixed lineage leukemia. HBV
integrations in KMT2B in HCC may mirror KMT2A rearrangements in leukemia, but its function has not been
studied. We have identified patient-derived HCC cell lines carrying HBV integrations in KMT2B. Using these cell
lines and RNA-seq data of HCC tumors with HBV integrations in KMT2B, we found that these integrations lead
to expression of truncated KMT2B from the N-terminus to 697 to 906 amino acid residues. Knockout of the
KMT2B truncation in an integration-carrying cell line suppressed cell proliferation in vitro. Overexpression of a
KMT2B truncation transformed normal human hepatocytes in vitro and induced tumor growth in vivo in
hydrodynamic injection-based mouse models. Mechanistically, we found the KMT2B truncation sequestered the
tumor suppressor MENIN from the KMT2A/B histone methyltransferase complex and chromosome. A KMT2B
truncation carrying a mutation that blocks MENIN binding failed to promote tumor formation in vivo. Based on
these preliminary data, our central hypothesis is that HBV integrations in KMT2B produce truncations, which
sequester MENIN from KMT2B complex and promote hepatocellular carcinoma. To test this hypothesis,
we will determine the oncogenic function of KMT2B truncations, using various in vitro and in vivo models (Aim
1), and determine the mechanism of KMT2B truncation-triggered tumorigenesis (Aim2). Specifically, a new
genetic engineered mouse model of HCC will be generated and a potential targeted agent for HCC with HBV
integrations in KMT2B will be tested. The proposed studies aim to establish the oncogenic driving function and
mechanism of HBV integrations in KMT2B in HCC, which cause 35,000 HCC cases every year. It is among the
most common cancer-causing genetic alterations but it is significantly understudied. The completion of the
proposed studies will discover a novel oncovirus-driving, epigenetic mechanism of HCC development and
provide information for developing prevention approaches, early detection assays, and targeted therapeutics for
affected individuals.

Public health relevance
PROJECT NARRATIVE Hepatitis B virus (HBV)-driven hepatocellular carcinoma (HCC) is among the most deadly cancers worldwide and disproportionally affects minority groups and immigrants in the US. We found 10% of HBV+ HCC tumors carry clonal integrations of HBV sequences in the KMT2B gene within the cancer genome, which affect about 35,000 HCC cases yearly. This project will investigate this understudied oncogenic event, discover how these integrations cause cancer, and provide novel targeted strategies to treat patients.